Rapid Testing of Drug Resistant BCR-ABL(+) Leukemia Cells

DESCRIPTION (provided by applicant): Resistance to chemotherapeutic drugs is an ongoing problem that results in eventual treatment failures or suboptimal patient outcomes. Approximately one-quarter of BCR-ABL(+) leukemia patients demonstrate evidence of resistance to imatinib mesylate either at initial diagnosis or at some point after treatment has begun. In our Phase I investigation, we demonstrated that monitoring the cellular stress developed by BCR-ABL(+) leukemia cells in response to tyrosine kinase inhibiting (TKI) drugs can used as an early marker for determining the effect of the therapeutic agents on the cancer cells. The approach is optimally implemented by measuring the dielectric permittivity of drug-treated cell suspensions using differential impedance sensing. Corresponding measurements of drug-sensitive and drug-resistant BCR-ABL(+) cell lines were obtained and confirmed by MTT assay. The response of non-leukemic peripheral blood mononuclear cells (PBMCs) to TKIs measured at clinically relevant drug concentrations showed no significant background level. Finally, the responses of BCR-ABL(+) patient blood to different TKIs were consistent with our initial cell line measurements laying the foundation for a practical clinical assay. In this Phase I effort we propose to quantify the cellular stress related drug responses enabling ease in interpretation of results, develop prototype instrumentation, verify the technical approach through animal model measurements and demonstrate feasibility with patient samples.

Public health relevance
PUBLIC HEALTH RELEVANCE: The development of a rapid diagnostic tool for determining the sensitivity/resistance profiles of leukemia cells to therapeutic agents is a significant step towards the administration of personalized medicine and optimal patient outcomes. By addressing and overcoming a significant technical barrier (the ability to determine the effects of a therapeutic agent on difficult to culture cancer cells), the proposed project enables drug-resistant cancer cells to be distinguished from drug-sensitive cells easily and rapidly. The availability of this diagnostic tool will arm oncologists with knowledge of the most effective drug for eliminating the cancer cells and the ability to monitor the onset of drug resistance during the administration of treatment. These new capabilities will avoid the empirical prescription of cancer therapy and enable the start or modification of existing treatment choices as needed. While this project focuses on the chemosensitivity testing of leukemia cells to tyrosine kinase inhibiting agents and the identification of drug resistance as an initial demonstration of its feasibility, the technical approach is applicable to a spectrum of different cancer types and therapeutic agents. __SpecificAimsTextDelimiter__ Specific Aims Resistance to chemotherapeutic drugs is an ongoing problem that results in eventual treatment failures or suboptimal patient outcomes. Despite the extraordinary success treating BCR-ABL(+) leukemias with tyrosine kinase inhibitor (TKI) drugs, approximately one-quarter of patients demonstrate evidence of resistance to imatinib mesylate either at initial diagnosis or at some point after treatment has begun [1]. While genotypic assays are proficient at identifying the BCR-ABL oncogene in peripheral blood or marrow, testing does not involve the drug and actual cell function is not measured. To address this diagnostic limitation, BioSense Technologies proposed a new rapid assay to determine the chemosensitivity of BCR-ABL(+) leukemia cells in peripheral blood mononuclear cells (PBMC) isolated from blood or marrow samples. The assay is based on the discovery of a new sensing modality to monitor even small changes in the cellular metabolism of stressed cells in complex samples. The approach is optimally implemented by measuring the dielectric permittivity of drug-treated cell suspensions using differential impedance sensing. The development of stress in drug-treated sensitive cells is the first step in the subsequent cascade leading to eventual cell death (apoptotic, necrotic or autophagy). The intensity of this response is also an early measure of the effect of the drug on the cell. The ability to distinguish stressed (drug-sensitive) from unstressed (drug-resistant) cells during exposure to therapeutic agents with an operationally simple assay enables the determination of drug sensitivity profiles for leukemia cells and targeted therapies for improved patient outcomes. In our Phase I investigation, we successfully demonstrated that monitoring the cellular stress developed by BCR-ABL(+) leukemia cells in response to tyrosine kinase inhibiting (TKI) drugs can used as an early marker for determining the effect of therapeutic agents on the cancer cells. Specifically: 1.) Impedance measurements of drug-sensitive and drug-resistant BCR-ABL(+) cell lines were demonstrated to be unique and easily distinguishable and confirmed by MTT assay; 2.) The response of normal peripheral blood mononuclear cells (PBMCs) to TKIs were measured at clinically relevant drug concentrations and showed no significant background levels; and 3.) Impedance responses of BCR-ABL(+) patient blood to different TKIs were consistent with cell line measurements laying the foundation for a practical clinical assay. In this Phase II effort, we hypothesize that these early responses can be quantified and used to compare the effectiveness of different therapeutic agents for eliminating BCR-ABL(+) leukemia cancer cells. The Specific Aims for this Phase II effort are: " Specific Aim 1. Incorporate Improvements to Prototype Instrumentation. We propose to modify the instrumentation used for our Phase I measurements to improve reliability and reproducibility, reduce cost per assay, and increase testing throughput. As part of this Aim, the number of test channels will be expanding and technical approaches to produce disposable test cassettes will be investigated. " Specific Aim 2. Quantify the Dielectric Sensitivity of BCR-ABL(+) Cells to Tyrosine Kinase Inhibitor Drugs. In Aim 2, we propose to develop a method for quantifying the impedance responses from different therapeutic agents enabling the direct comparison of their effectiveness in killing cancer cells. In addition, chemosensitivity measurements of BCR-ABL(+) stem cells to TKIs will be obtained. " Specific Aim 3: Verify the Dielectric Responses of Animal and Human Blood Samples. In the final Aim we propose to confirm the cell line chemosensitive measurements using a BCR-ABL cell line based mouse model and selected human blood samples in collaboration with Dr. Richard Stone at the Dana Farber Cancer Institute (DFCI). Finally, measurements of drug-resistant FLT3+ AML cells will be obtained to demonstrate the applicability of the technology to other cancers. Research Strategy Significance. The tyrosine kinase inhibitors (TKI), imatinib mesylate and the two second-generation agents dasatinib and nilotinib, have revolutionized the treatment of the BCR-ABL(+) leukemias chronic myeloid leukemia (CML) as well as acute lymphoblastic leukemia (ALL) thereby "converting a fatal cancer into a manageable chronic condition" [2]. However, despite the successes of these novel drugs, treatment failures due to intrinsic or acquired drug resistance continue to be present in a sub-population of BCR-ABL(+) cancer patients.